Elucidating 3D Constructs of Reentrant Circuits via a Novel Noninvasive Hybrid-AI System

Project Summary
Scar-mediated ventricular tachycardia (VT) is responsible for over 350,000 sudden cardiac deaths each year in
the US. It is often caused by a reentrant circuit, maintained by narrow channels of surviving tissue (critical
isthmus) protected within fibrotic tissue in the heart. While catheter ablation is used to treat VT by ablating the
critical isthmus, its current decision support is based on a 2D interpretation of the reentrant circuit on one
ventricular surface. This oversimplifies the 3D morphology of a reentrant circuit across the ventricular wall,
leading to suboptimal ablation strategies and leaving a critical void of noninvasive decision support for ablation
targeting that elucidates the 3D construct of a reentrant circuit beneath surfaces. A pivotal barrier to progress is
the minute signal of reentrant circuit compared to its subsequent ventricular activity as manifested on body-
surface electrocardiograms (ECGs), rendering it an easily-missed needle in a haystack. This proposal aims to
fill this void by a hybrid neural-physics AI system that models and identifies the reentrant circuit as an unknown
cause (modeled by neural networks) of a well-known effect (modeled by known physiology). It builds on
significant progress from our last award, especially preliminary data on 1) the feasibility of extracting from
ECGs signatures about the intramural depth of a reentrant circuit, 2) a hybrid-AI foundation prototyped in
various complex systems including the heart, and 3) a unique multi-site capability to create an unprecedented
in-silico and in-vivo dataset about 3D reentrant circuits for training and testing the AI system. Our long-term
goal is to deliver a one-of-its-kind hybrid-AI system that can easily fit into the clinical workflow of scar-mediated
VT ablation to inform clinicians with possible 3D constructs of an observed clinical VT. Our specific aims are:
1) To develop and evaluate hybrid-AI for elucidating intramural exit sites in stable VTs.
2) To develop and evaluate hybrid-AI for elucidating 3D critical isthmus in stable VTs.
3) Retrospective internal and external clinical evaluation in stable and unstable VTs.
The multidisciplinary investigating team includes a technical core with expertise in AI and virtual-heart
simulation, and clinical core with expertise in imaging as it relates to arrhythmia and VT ablation, endo-epi
mapping of 3D VT constructs, and AI adoption in VT ablation. The outcome of this research will improve
clinical practice of VT ablation by an unprecedented decision support to simplify procedural planning, shorten
procedural time, reduce trial-and-errors, and improve procedural outcomes. The in-silico and in-vivo database
generated will provide unparalleled capabilities for scientific discovery about the mechanisms of scar-mediated
VT. Finally, the proposed hybrid-AI system will advance the AI foundation to be less demanding on data
annotation while being more interpretable and trustworthy, contributing to better AI adoption in medical practice.

Public health relevance
Project Narrative Life-threatening episodes of ventricular tachycardia (VT) are often caused by a 3D reentrant circuit situated within the heart wall. While this reentrant circuit can be targeted by catheter ablation to treat VT, the current decision support for catheter ablation relies on a 2D interpretation of the reentrant circuit on one surface of the heart. This research will develop a one-of-its-kind hybrid-AI system to advance the capability and accessibility of decision support in VT ablation by elucidating the 3D construct of scar-mediated reentrant circuits using noninvasive data routinely available in standard of care.